Mississippi INBRE

High performance compute infrastructure has led to numerous breakthroughs and spurred increasing inclusion
of bioinformatics approaches by researchers. For many academic scientists, computation is accomplished with
local resources or those shared at partner institutes. Unfortunately, these systems become obsolete over time
and due to high demand may have long job queues. Thus, there is a relentless need to modernize and expand
computational resources. One potential solution is cloud computing where commercial systems for scalability.
To prepare a biomedical workforce for this paradigm shifting in data science, NIGMS launched training modules
in the NIGMS Sandbox for a variety of users to become competent in cloud computing. This proposal will expand
these offerings to provide new modules specifically targeted to the undergraduate classroom. Their inclusion will
expand the reach of NIGMS cloud training resources to very early career scientists and faculty who might not
otherwise engage in cloud computing. To serve diverse interests, the modules will be available for artificial
intelligence/machine learning (AI/ML), structural biology, and epidemiology research. The modules to be
developed with this supplement will include lightweight datasets for exploring code. This will lead to minor
compute time costs such that standard lab fees associated with a course will be sufficient to fund module
activities. All modules will be designed to fit within up to five standard 150 minute class periods, giving faculty
who adopt the curriculum the ability to include other topics in a semester. Thus, the modules can be worked into
a variety of courses.

Public health relevance
Computation of biological data benefits from access to contemporary environments and equipment. Cloud computing offers a solution to relentless need to modernize and expand computational resources. This project will provide cloud computing lessons for the undergraduate classroom so students can begin their careers using the most future proof option.